Developing and validating serological assays to SARS-COV-2 for highly susceptible animal species

Project Summary
SARS-CoV-2 is an enveloped, positive-sense RNA virus that is known to interact with the angiotensin-
converting enzyme-2 (ACE2) receptor of several species, including humans, cats, dogs, minks, ferrets, deer,
and others. Since its emergence in Wuhan, China in late 2019, SARS-CoV-2, the causative agent of COVID-
19, has been classified as a pandemic, causing havoc on public health and resulting in worldwide lockdowns.
Due to its sudden emergence, as well as its similarity to SARS-CoV-1 and MERS-CoV, it is suspected that
SARS-CoV-2 likely had an intermediate animal host. However, the similarities in the ACE2 receptors of
coronaviruses have sparked the question of which animal species are susceptible to SARS-CoV-2, and
capable of viral transmission. Reverse-zoonosis has been described in a few of these species, indicating that
human-animal interactions can pose two-sided risks for SARS-CoV-2 infection. Therefore, it is critical to
produce accurate diagnostic serological tests for animals to understand prevalence of the virus in the animal
population. This project will compare diagnostic results between commercial ELISAs, developed in-house
ELISAs, and serum neutralization assays for SARS-CoV-2, as well as Western blot against other
coronaviruses to rule out cross-reactivity. The outcome of this study will provide insight into the accuracy
(Se/Sp) of commercially available serological tests, newly developed in-house serological techniques, and
collect data on SARS-CoV-2 prevalence in target species, which will include minks, ferrets, white-tailed deer,
domestic dogs and cats, cows, sheep, and goats.

Public health relevance
Project Narrative The primary goal of this project is to develop diagnostic serological assays (ELISAs and virus neutralization) to detect SARS-CoV-2 antibodies in susceptible animal species in order to assess the seroprevalence of SARS- CoV-2 and level of neutralizing antibodies in these species. The secondary goal is to compare the performance of our in-house tests to commercial ELISA tests for SARS-CoV-2, and the third goal is to assess the relative specificity and sensitivity of these assays using known positive and negative serum samples from studies. Our data analysis will show which species are susceptible to SARS-CoV-2 and give insights into the seroprevalence of SARS-CoV-2 antibodies in these species.